Admin Core

ABSTRACT – ADMINISTRATIVE CORE
The highly integrated nature of the University of Michigan (UM) Kidney, Urology and Hematology Research
Training Network (KUHR) requires a robust and active Administrative Core. The major goals of the Core will be
to coordinate workflow, distribution of resources and operations assessment of the UM-KUHR, achieved
through the following specific aims. Specific Aim 1: To optimize interaction and coordination across the
U2C Cores and the TL1 and promote Diversity, Equity and Inclusion. The Administrative Core will oversee
program organization, governance, collaboration and communication, as well set the processes for self-
evaluation and continued improvement. The Core will facilitate collaborative leadership and communication
between U2C Principal Investigators, U2C Professional Development and Networking Cores and TL1 training
component Project Leads. It will also coordinate with other institutional training programs and external U2C
network institutions. In addition, the Administrative Core will organize, stimulate and evaluate interactions of
the Program with our Institutional trainees and mentors to ensure that the networking and educational
programs are providing optimal support. It will conduct ongoing review of the Training Program through
collection of objective metrics and rigorous feedback from trainees, mentors and the Internal Advisory Board.
The Core in consultation with NIDDK will establish an External Evaluation Board (EEB) that would meet
annually to review progress and provide feedback for self-improvement. Specific Aim 2: To ensure
appropriate allocation of resources for effective administration of the UM-KUHR. The Administrative
Core will oversee the resource expenditures of the Program and will be responsible for the reporting to internal
and external stakeholders and to the NIH. The Administrative Core, through the Core's Leadership Working
Group, will oversee all Cores, ensuring that expenditure of cost-share funds are properly allocated to support
educational objectives. Specific Aim 3: To ensure promotion and visibility of the Program across the
institution and regional collaborations. The Administrative Core will maintain a website for public use to
promote program activities. The Core will continue to support a Regional Educational Retreat for trainees and
mentors, including those at our regional sites, to highlight research advances and review trainee research
progress. The Core will also assist the NIDDK U2C Network in coordinating the annual NIDDK retreat.